Links between rRNA and tRNA modifications, codon use, translation, and metabolism in cancer cells

Project Summary
Post-transcriptional RNA modifications are a ubiquitous feature of the stable RNAs of the
translation apparatus, with attributed functions including biogenesis, stabilization of rRNA
structure, and promoting the fidelity of translation. There is recent mounting evidence that rRNA
and tRNA modifications play an important role as a second layer of the genetic code, tuning
gene expression in response to cellular cues, and in particular altered modification states have
been implicated in many types of cancers. This proposal seeks to understand the fundamental
biology of rRNA and tRNA modifications as they contribute to altered gene expression
supporting tumorigenesis, exploring a critical link between modifications and methionine
metabolism.
The overall goal of this work will be to identify correlations in modification state of the translation
apparatus with changes in codon occupancy and translation rate, and to map these correlations
across cancer cell lines to uncover the key link to methionine starvation. These data will offer
further insights into how methionine starvation might mediate or limit cancer cell growth,
informing ongoing efforts to target this pathway therapeutically. There is certain to be a
fundamental relationship between the availability of methyl groups for RNA modification and
gene expression patterns, and the work outlined in this proposal will serve as a strong
foundation for subsequent studies on the roles of the many other types of modifications in
altered programs of gene expression.

Public health relevance
Project Narrative This project seeks to understand the relationship between methionine metabolism, methyl modification of the ribosomal and transfer RNAs, and gene expression in cancer cells. The overall goal is to understand how methyl modifications contribute to cancer, and to identify cancer specific metabolic effects that could be exploited by targeting the respective methyltransferases.